A novel siRNA therapeutic to prevent scarring and bleb failure after trabeculectomy

Abstract
Glaucoma is the leading cause of irreversible blindness, affecting tens of millions of citizens
globally. Trabeculectomy surgery, is the gold standard for reducing intraocular pressure (IOP) in
glaucoma patients who no longer respond to medical therapy. However, the long-term success of
trabeculectomy is compromised by postoperative scarring. Scarring, which leads to increased
IOP after surgery, occurs in 50% of patients within five years, significantly diminishing surgery
effectiveness and increasing the risk of vision loss. Our project focuses on the development of
DUB-001, an innovative therapeutic designed to prevent scarring after trabeculectomy surgery.
DUB-001 is a fully modified self-delivering siRNA (sdRNA) targeting the USP10 gene which we
have identified as a critical regulator of the fibrotic response in the eye. DUB-001 is unique in its
design as it is conjugated to a cholesterol moiety, allowing for direct absorption into the wounded
tissue without the need for encapsulation. Preclinical studies have demonstrated that a single
administration of USP10-targeting sdRNA provides prolonged anti-fibrotic activity after surgery
throughout the phases of wound healing, compared to the standard of care (Mitomycin C). By
modulating USP10 activity, DUB-001 aims to reduce scar formation, thereby increasing long-term
success of trabeculectomy procedures. The proposed research will advance DUB-001 through
critical preclinical development stages including, therapeutic effect, safety, tolerability, and drug
biodistribution studies in rabbit and minipig. In preparation for an IND-filing, the project will also
support scaled-up production of DUB-001 in its GLP final formulation. The production runs will be
used to conduct future IND-enabling studies including toxicology and PK experiments in minipigs.
At the conclusion of the project, DUB Tx will have completed all required efficacy studies,
demonstrated a clear safety profile for DUB-001 in a pharmacologically relevant animal model,
and created a scaled-up manufacturing process ready for cGMP conversion. These data
significantly derisk the therapeutic pipeline for this indication, enabling external investment to fund
the remaining IND-enabling studies and early-stage clinical trials. By preventing postoperative
scarring, DUB-001 has the potential to increase the success rate of trabeculectomy surgeries,
reduce the need for repeat surgeries, and preserve vision in glaucoma patients. This will ultimately
alleviate the global burden of glaucoma-related blindness and reduce healthcare costs associated
with this chronic disease.

Public health relevance
DUB Therapeutics is developing an innovative anti-scarring drug designed to enhance the long- term success of trabeculectomy surgery in glaucoma patients. DUB-001 is a self-delivering siRNA that can be topically applied, or injected, demonstrating prolonged efficacy with one dose. This project will advance DUB-001 through preclinical efficacy and safety studies in a trabeculectomy model, while also establishing a scalable manufacturing process, paving the way for clinical approval with the goal of reducing the global burden of glaucoma-related blindness.